Nitric Oxide Regulation of Inflammatory Responses and Ge

Introduction and Objective: Nitric oxide is an important inter- and intracellular messenger implicated in the pathogenesis of septic shock. Inhibition of nitric oxide synthase is under investigation as a treatment for hypotension in septic shock. Furthermore, inhaled nitric oxide is under investigation as a therapy for respiratory distress syndrome in neonates and adults. In addition to its vasodilating effects on the systemic and pulmonary vasculatures, nitric oxide also modulates immune responses and regulates gene expression. These latter attributes may have implications for the use of nitric oxide synthase inhibitors or nitric oxide itself for syndromes in which the host’s inflammatory response plays a pathogenic role. In this project, we are examining the role of nitric oxide as a modulator of inflammation and gene expression. Progress: Human phagocytes, in particular neutrophils, were demonstrated to lack the capacity to endogenously produce nitric oxide under a number of ex vivo and in vivo conditions. Therefore, the ability of these cells to be regulated in a paracrine manner by exogenous sources of NO such as the endothelium has been explored. In addition to upregulating TNFa production, nitric oxide was found to modulate IL-8 mRNA levels and IL-8 production in human neutrophil preparations. We have confirmed that endogenously produced nitric oxide also up-regulates TNFa production using human U937 cells, a monoblastoid cell line, transfected to express murine inducible nitric oxide synthase. Investigation of TNFa regulation by nitric oxide resulted in the description of a cGMP-independent signaling pathway that utilizes cAMP downregulation as a signal transduction event. A nitric oxide-responsive Sp1 binding site was identified in the proximal TNFa promoter. NO-mediated decreases in cAMP leads to reduced Sp1 binding to the TNFa promoter with subsequent increases in TNFa transcription. Recent work has shown that NO downregulates the eNOS promoter through effects on Sp1 identical to those that cause TNFa upregulation. For TNFa, an AP1 site upstream to Sp1 serves to reverse the direction of the nitric oxide response. Mutation of the AP1 site converts the effect of nitric oxide in TNFa from up to down regulation (eNOS-like). The IL-8 promoter lacks a canonical Sp1 site. Unlike TNFa, IL-8 regulation by nitric oxide is both cGMP and cAMP-independent. Further, nitric oxide p38 MAPK-dependent effect on protein binding to regulation of IL-8 has been found to be post-transcriptional and mediated via AU-rich elements in its mRNA 3? UTR. An oligonucleotide microarray analysis in differentiated U937 cells has identified more than 100 additional nitric oxide regulated genes. Proposed Course of Work: Current work is focused on identifying all major pathways of nitric oxide gene regulation using microarray and molecular biology approaches. Part of this effort is directed toward characterizing nitric oxide effects on the cell-cycle and the respective roles of p38 MAPK, proteasome inhibition, and mRNA stability on gene regulation by nitric oxide. Separate experiments are directed at profiling the effects of nitric oxide and inflammatory mediators such as endotoxin, TNFa, and HMG-B1 on a variety of primary cell types including neutrophils, elutriated monocytes, and endothelial cells.